Computational Modeling of the Interplay between External Signaling and Transcription Rewiring using Spatial Transcriptomics and Single Cell Multiome Data

Project Summary/ Abstract
Cell-cell interactions (CCI) play crucial roles in nearly all important biological processes, including cell
differentiation, inflammation, wound repair and oncogenesis. CCI typically occurs when a sender cell's ligand
interacts with a receiver cell's receptor, leading to changes in the target cell's transcription factor (TF) activities.
Despite the advances in high-throughput methods, there is still a gap in the identification of CCIs from these
data, relying largely on low-throughput manual methods.
To address this gap, the proposed research aims to develop computational frameworks to model
the impact of external signals on a cell's internal TF activity using a combination of single-cell
multiome (scMultiome) and spatial transcriptomics (ST) data. The PI plans to create a series of
computational methods based on his prior work, including: 1) DeepPrism, an improved version of BayesPrism,
to more accurately deconvolve cell type fraction and cell type-specific gene expression from bulk RNA-seq and
ST. 2) SpaceNiche, a method for jointly modeling the relationship between CCI and downstream gene
expression using ST and provide interpretable biological insights about CCI. 3) RegulatoryVAE, a tool to infer
TF activity and the relationship between regulatory elements and target genes from scMultiome which contains
both the chromatin accessibility (ATAC) and gene transcription information. 4) NicheOT, a method to integrate
TF activity learned from scMultiome and the spatial context learned from ST. 5) CARCell, a tool to quantify the
impact of CCI on TF activity and their changes in diseased states.
These tools will be able to address the significant limitations in existing methods including 1) inability to
account for heterogenous gene expression and to use multiple scRNA-seq reference to perform statistical
deconvolution, 2) the reliance on the transcription level of receptor/ligand to impute CCI, which may not reflect
active protein levels and may fail to account for ineffective interactions due to physical separation or epigenetic
states, and 3) the reliance on incomplete motif information to infer TF activity and the existing model’s
inefficiency in capturing the complex relationship between DNA sequence and TF activity.
The proposed methods will be applied to study the impact of CCI on inflammatory bowel disease (IBD)
using scRNA-seq, scMultiome, and Visium data collected by a collaborator. IBD affects nearly 1.3% of adults in
the US and its prevalence is increasing globally. Mis-regulated CCI is a key feature of the disease. By
providing a generalizable tool for understanding CCI using ST and scMultiome, this work aims to fill the current
gap in computational methodologies and advance the understanding of IBD, with the goal of developing new
therapeutic targets.

Public health relevance
Project Narrative Cell-cell interaction plays a crucial role in many biological processes, including cell differentiation, inflammation, wound repair and oncogenesis. Current methods for identifying cell-cell interactions are mainly through low-throughput manual techniques, leaving a disconnect between advancements in high-throughput methods and the identification of biologically meaningful interactions. This proposal aims to bridge this gap by creating computational frameworks that comprehend the impact of external signals on a cell's internal transcription factor activity using a combination of single-cell multiome and spatial transcriptomics data.